Controlled Protein Translocation in Nanopores for Sequencing Applications

Project Summary
In the field of proteomics, the ultimate goal is to determine the sequence and abundance of every protein variant
in a sample. To reach this goal, we need techniques capable of single-molecule, high-accuracy, de novo protein
sequencing. Unfortunately, current proteomics technologies lack the sensitivity, dynamic range, throughput,
scale, and accuracy needed to meet this goal. During this project, we will develop technological components and
methods required to enable state-of-the-art protein sequencing. More specifically, we will develop methods for
controllably translocating a protein through a nanopore reader such that the protein can be sequenced with single
amino acid resolution. Nanopore-based sequencing provides a path to characterizing both high- and low-
abundance proteins by sequencing proteins one molecule at a time, but with the high accuracy, sensitivity and
throughput needed to cover the wide dynamic range in protein abundance in the proteome. During this project,
we will develop and build a novel prototype sequencing system, fully assess and optimize the associated
workflow/methodology for highly accurate, reproducible, and versatile protein/peptide characterization, and
demonstrate initial sequencing for various proteins and peptides. At the conclusion of this project, we will have
successfully demonstrated feasibility for a practical nanopore-based protein sequencing concept.

Public health relevance
Project Narrative The goal of this program is to develop and validate the individual components and overall methodology for a new protein sequencing technology, based on nanopores, that will enable direct, de novo, single-molecule sequencing with the ability to identify individual amino acids in proteins and peptides. The ability to perform high throughput protein sequencing will ultimately supersede existing protein detection methods, and will be an indispensable tool for biological research, including assessing gene expression, protein variants, post translational modifications, and disease biomarkers, eventually enabling the associated clinical testing and disease monitoring.